Mechanism of LSD1 Function and Its Therapeutic Application for Progressive Oral Malignancy

Abstract
Lysine-specific demethylase 1 (LSD1) is a nuclear histone demethylase. Our work shows that LSD1 expression
progressively increases with tumor grade and stage in clinical oral squamous cell carcinoma (OSCC). Our long-
term goal is to evaluate LSD1 mechanism in progressive oral malignancy based on preliminary studies for
therapeutic applications. Recent preliminary studies showed that conditional LSD1 deletion in the tongue
epithelium during dysplasia reduced invasive pathological lesions, downregulated EGFR, YAP-induced signaling
network, and Pd-L1 expression. Next, the topical application of LSD1 inhibitor during dysplasia prevented its
progression to invasive phenotype, attenuated pathological lesions, expression of Hippo signaling effectors (Yap,
Taz, Ccn2,) and immune checkpoints (Pd-1, and Pd-l1). LSD1 inhibitor sensitized OSCC to combinations with
either YAP inhibitor, anti-PD-1, or anti-PD-L1 antibodies, limiting tumor progression in vivo. Thus, we showed
for the first time that blocking LSD1 inhibits preneoplasia, a feed-forward loop during the progression of
dysplasia to OSCC. Interestingly, LSD1 inhibition attenuates IL-6-JAK-STAT3 novel signaling identified in two
independent studies 1) proteomics analysis of LSD knockout mice preneoplasia and 2) single-cell RNAseq
analysis using LSD1 inhibitor. However, the mechanism of LSD1 function, its target cells in progressive oral
malignancy, and how LSD1 promotes IL-6-JAK-STAT3 remain unclear. This knowledge gap prevents the
targeted design of effective new epigenetic therapeutic strategies for OSCC. We hypothesize that (1) LSD1
upregulation during dysplasia reprograms oral tissue to invasive phenotype by acting on IL6 -signaling and
induced cell types and (2) pharmacological attenuation of LSD1 reset epigenome to reverse progressive
malignant preneoplasia to a noninvasive phenotype. Using clinically relevant animal models, this project is well-
positioned to address the following Specific Aims: 1) to determine how upregulated LSD1 epigenetically
reprogram dysplasia to promote IL6 network during progressive oral preneoplasia invasive phenotype; 2) to
determine if LSD1 collaborates with YAP to promote IL6-JAK-STAT3 network induced invasive phenotype in
preneoplasia, and 3) to determine the translational importance of pharmacological LSD1 inhibition reverse
preneoplasia by inhibiting IL6-JAK-STAT3 signaling induced cancer stem and immune cells. The successful
completion of the proposed project is expected to identify LSD1 and therapeutic application mechanisms in the
IL6-JAK-STAT3 network, related stem cells, and immune cells. Finally, the study will determine if LSD1 a role
in anti-PD-1 immunotherapy resistance and pharmacological LSD1 inhibition can attenuate feline OSCC for a
potential application in veterinary and human medicine. Overall, the study will have a broader impact on future
translational studies in human preneoplasia.

Public health relevance
Project Narrative Oral cancer represents a significant societal burden. In this project, we propose to identify the key underlying causes of oral cancer by investigating changes in the chromatin environment brought about by an enzyme, lysine-specific demethylase 1 (LSD1). We anticipate that this study will increase knowledge about the biology of oral cancer, explore a synergistic combination of effective therapy, and lead to the development of novel treatment strategies for this pernicious disease.